Couple Communication in Cancer: A Multi-Method Examination - Renewal - 1

PROJECT SUMMARY
For persons with cancer and their intimate partners, the ability to communicate effectively about cancer-related
issues impacts the adjustment of both individuals and their relationships. However, the vast majority of
research on couple communication in cancer has been limited by reliance on global self-report measures of
communication that focus on a single dimension of communication behavior (e.g., disclosure versus
avoidance) without consideration of other potentially important processes such as emotional arousal, the
quality of emotions expressed, and sequences and trajectories of communication behaviors. This narrow focus
has prohibited advancements in our understanding of communication processes which, in turn, limits efforts to
develop efficacious interventions and target them to couples most at risk of poor adjustment. The proposed
study will address these limitations by leveraging a large longitudinal, multi-method dataset we collected
among 353 couples coping with stage II-IV breast, colon, rectal, and lung cancer (R01 CA201179). Participants
completed global self-report measures of communication four times over a one-year period; twice-daily
ecological momentary assessments (EMA) over two weeks; and audio- and video-recorded couple
conversations of cancer-related topics from which we coded affective expressions and communicative
behaviors and obtained data on fundamental frequency, a novel objective indicator of vocally expressed
emotional arousal. Preliminary results provided support for two theories of couple communication in cancer
(Social Cognitive Processing and Relationship Intimacy) and underscored the utility of different indicators of
communication in predicting adjustment. While these findings are promising, our original aims and methods
relied on single indicators of communication in isolation, and thus did not fully capitalize on the integrative
potential of the dataset. Recent advances in relationship science suggest that the integration of self-report,
behavioral, and fundamental frequency data can provide a richer and more sophisticated picture of
communication processes and their impacts on intra- and interpersonal outcomes. This in turn can inform the
development of more targeted and efficacious interventions. Specific aims of this proposal are: (1) To identify
communication profiles of couples based on EMA and observational data. (2) To examine the predictive
relationship of these communication profiles to outcomes including patient and partner psychological
adjustment, relational functioning, and physical and functional well-being collected at the 12-month follow up.
(3a) To develop, using machine learning, a brief self-report screening tool that will identify couples most at risk
for poor outcomes based on the communication profiles developed and tested in Aims 1-2. (3b) To
concurrently and prospectively validate this brief screening tool in a new sample of 270 couples (patients with
stage II-IV breast, colorectal, or lung cancer and their partners). (3c) To identify facilitators and barriers to
implementation of the screener in a clinical setting. The goal is development of an efficient, empirically-derived
measure that can be administered to patients and partners in real-world clinical settings.

Public health relevance
NARRATIVE Dealing with cancer places great stress not only on the patient but also on that patient's spouse or partner, and couples find that communicating about cancer and how it is affecting their lives and relationship can become challenging even in the best of relationships. This study looks at how couples dealing with cancer communicate with each other across settings and time (within a single conversation and over the course of days and months), and whether patterns of communication can be identified that are associated with better or worse long-term emotional and relationship adjustment and well-being. This information will be used to develop screening tools to identify couples who may need more support and to explore how these tools can be used in clinical settings.